Bioenergetic impairment in Group 3 pulmonary hypertension

Pulmonary hypertension (PH) resulting from underlying chronic lung disease (Group 3, CLD-PH) is a common
disorder associated with significant symptoms and risk of death. Traditional concepts of CLD-PH pathogenesis
focus on mechanisms of hypoxic pulmonary vasoconstriction yet vasodilating therapies have failed to provide
benefit for CLD-PH patients. Current evidence indicates that pro-proliferative and anti-apoptotic changes in
pulmonary vascular cells lead to CLD-PH through progressive pulmonary vascular remodeling. Altered
mitochondrial energy metabolism plays a key role in this pulmonary vascular remodeling and is a potential but
unexploited treatment target. This proposal outlines research and training that will enable the PI to build on his
experience in clinical PH care and epidemiology. The PI’s long-term goal is to become an independent
collaborative leader in patient-oriented clinical and translational research focused on developing and evaluating
novel treatment approaches for CLD-PH. To achieve this goal, the PI will require further training in: 1) practical
and theoretical aspects of cellular metabolic phenotyping and application to human samples; and 2) conduct of
prospective clinical trials to assess mechanistically-targeted interventions in patients with PH. Abundant
preclinical evidence demonstrates that reductions in the expression and function of the major metabolic
regulator, peroxisome proliferator-activated receptor gamma (PPARγ), play a critical role in mitochondrial and
metabolic derangements in pulmonary vascular cells. Evolving evidence demonstrates that abnormal
mitochondrial metabolism extends beyond pulmonary vascular tissues and is observed in right ventricle
cardiomyocytes, skeletal muscle, and circulating platelets, suggesting more global metabolic perturbations in
PH. Further, activation of PPARγ with clinically available, antidiabetic, thiazolidinedione (TZD) medications can
prevent or reverse experimental PH. The overarching hypothesis for this project is that mitochondrial
bioenergetic derangements in CLD-PH are reflected in circulating platelets and can be improved with TZD
therapy. Aim 1 will examine platelet glycolytic and mitochondrial bioenergetic function in a cross-sectional
study recruiting subjects with CLD-PH, CLD without PH, and healthy controls. The proposed studies will
provide the first definition of bioenergetic function in freshly isolated CLD-PH platelets and test for ex vivo
treatment with pioglitazone (a TZD). Aim 2 will involve a phase 2 randomized cross-over trial to assess the
metabolic impact of pioglitazone in CLD-PH patients. The influence of pioglitazone versus placebo on
mitochondrial energy production will be assessed (primary mechanistic outcome) as well as safety and disease
efficacy (secondary outcomes). The proposal leverages an outstanding training plan and environment with the
support of an experienced multi-dimensional mentorship team to address a critical clinical need in the field of
pulmonary vascular biology. Completion of the proposed training and studies will position the PI to compete
successfully for independent funding and exert durable impact on the clinical management of PH.

Public health relevance
Pulmonary hypertension, the state of having high blood pressure in the lungs, affects more than 1.5 million U.S. adults, is more common with age, and causes significant respiratory symptoms and a higher risk of death. In a large portion of patients, pulmonary hypertension is the result of underlying chronic lung disease, and unfortunately, no direct treatment is available. This research project will evaluate metabolic abnormalities as an underlying and treatable cause of pulmonary hypertension in patients with chronic lung disease.